The development of a family navigator intervention and prevention protocol to reduce risk of suicide and self-injurious behavior for youth aged 10 to 14 years.

Pandemic-period changes have been observed in recent rates for youth aged 10 to 14 on suicidal and
non-suicidal self-injurious behavior (hereinafter referred to as SSIB), where they are now presenting with
SSIB at rapidly increasing rates. This unique group of youth is of great interest, because SSIB prevention
protocols are needed to reduce SSIB risk as well as decrease prevalence rates. Pediatric emergency
departments (EDs) have become an essential and often routine mental health service for youth. EDs are
optimal sites to initiate youth SSIB prevention protocol, as they are often the first point of entry for youth
into the mental health system. Despite high rates of youth seen in the ED for SSIB, effective ED
interventions to reduce SSIB risk and increase attendance and adherence to subsequent
community-based mental health care are lacking. The purpose of this pilot study is to develop and pilot a
Family Navigator (FN) with technology-enhanced information sharing via texting intervention for families
with youth who were discharged from the ED after an admission for SSIB. This intervention aims to
reduce SSIB risk and prevalence rates, as well as increase engagement in community-based mental
health services for youth aged 10 to 14. This intervention is informed by the literature, evidence-based
hospital intervention protocols, a family-based approach for youth development stages, and developed to
directly target three mechanisms. This study will develop a brief FN modeling enhanced with
technology-delivered information shared (automated sharing of information with families via text). Thus,
qualitative methods will be employed to assist in the refinement of the intervention, thus maximizing
ecological validity. At the outcome of this study, FN acceptability and feasibility as well as manual
development will be completed. Balanced randomization will occur to either the treatment as usual (TAU)
condition or the Family Navigator (FN) with information sharing condition. Primary outcomes, measured
at 4- and 6-month follow-ups, include reduce SSIB risk and prevalence rates, increased attendance and
adherence to youth community-based mental health care, and the engagement of the purported
therapeutic mechanisms. This pilot study will set the stage for a NIMH R01 application via a Type I Hybrid
Effectiveness-Implementation trial to speed translation of research findings to practice.